TREATMENT OF ENDOTHELIAL DYSFUNCTION

This protocol will study whether abnormal coronary vasomotion can be reversed by therapy to lower cholesterol. Restoration of endothelial funcion will be represented by the return of endothelium-dependent dilation to acetylcholine with the reversal of paradoxical constriction.